Curing chronic Toxoplasma infection with novel and potent protease inhibitors

PROJECT SUMMARY
Zero effective options exist for treating individuals who are chronically infected with the protozoan parasite
Toxoplasma gondii (Tg) as a source of reactivated toxoplasmosis. Reactivated Tg infection in the retina is a
leading cause of infectious posterior uveitis, impairing the vision of approximately 3,600 Americans annually.
Some individuals experience multiple episodes of reactivated ocular toxoplasmosis, with each bout further
eroding their vision. Eliminating Tg tissue cysts could preclude reactivated ocular toxoplasmosis and preserve
the vision of at-risk individuals. We have identified a Tg lysosomal protease (TgCPL) that is critical for chronic
Tg infection, developed several promising TgCPL-targeted lead compounds based on multiple scaffolds, and
established a mouse intravitreal ocular treatment model. Our long-term goal is to provide a safe and effective
treatment that eliminates chronic Tg infection from the retina after 2-week administration of a TgCPL inhibitor.
As a critical step toward this goal, the proposed studies will: (1) develop a computational structure-to-function
model of TgCPL to guide rationale discovery of novel ligands; (2) optimize the potency, pharmacokinetics, and
selectivity of our lead TgCPL inhibitors, including derived from novel ligands identified in aim 1; and (3)
eradicate chronic Tg infection in a mouse intravitreal ocular treatment model. Completing the proposed studies
will result in one or more advanced lead compounds suitable for further progression through the development
pipeline, thereby progressing toward a key unmet need for curbing chronic Tg infection.
1

Public health relevance
PROJECT NARRATIVE People who are persistently infected with the single-celled parasite Toxoplasma gondii are at risk of blindness due to reawakening of the infection in their eyes. Our long-term goal is to provide at-risk individuals with a safe and effective treatment that preserved vision by eliminating persistent T. gondii infection from their afflicted eyes. Toward this goal, the current project will develop new prospective drugs that cure the chronic ocular infection in mice as a critical steppingstone in advancing a novel treatment for use in patients. 1